ALDH2 DEFICIENCY--POPULATION GENETICS AND RELATIONSHIP TO PHENOTYPE

In Orientals, ALDH2 deficiency due to a common polymorphism frequently causes a flushing reaction after alcohol consumption and this aversive reaction is responsible for lower rates of alcoholism in individuals with the inactive ALDH2-2 allele. ALDH2 deficiency was detected in South American Indian populations; however, these findings have never been confirmed and a previous search for the Oriental ALDH2-2 allele in South American Indians was negative. R. Peterson identified a series of additional markers at ALDH2. By restriction enzyme analysis, SSCP, and sequencing, haplotypes characteristic for the ALDH2-2 and ALDH2-1 alleles were identified. This analysis has shed light on the origins and functional role of the variant ALDH2-2 allele, which appears to have appeared on a single haplotype lineage and spread among East Asian populations. Although ALDH22R [Glu487Lys] probably originated on a single genetic background, haplotype analysis reveals that it is sufficiently ancient for additional mutations to have occurred subsequently. The results on ALDH2 haplotypes are most compatible with an effect of selection to maintain the Oriental ALDH2 variant, Glu487Lys. We are investigating the relationship of ADH and ALDH functional alleles to alcoholism and other substance abuse phenotypes. These genotype/phenotype relationships are being studied in combination with other loci, for example the OPRM1 receptor locus in opioid addiction. - population research, ethnicity, gene mapping (human), molecular genetics, drinking patterns & causes